Incretin Microdosing for Cardiometabolic Health in People With HIV: The REINFORCE Trial

PROJECT SUMMARY
Cardiometabolic diseases are leading causes of non-AIDS-related morbidity and mortality among people living
with HIV (PWH). Obesity, a global epidemic, further increases cardiometabolic disease risk. Long-acting
glucagon-like peptide-1 receptor agonists (GLP-1RA) promote clinically significant weight loss and reduction of
cardiometabolic risk in adults with and without HIV. Problematically: there are no established strategies to
maintain therapeutic benefits of GLP-1RA except for continued, full-dose therapy; lifelong, high-dose GLP-1RA
therapy is impractical, costly and may have yet unknown risks; and drug cessation is associated with rapid weight
regain and loss of cardiometabolic benefit. As such, strategies to maintain benefit after initial induction therapy
are urgently needed. To fill this critical knowledge gap, and in response to PAS-23-086 Small R01s for Clinical
Trials Targeting Diseases within the Mission of NIDDK, we propose to determine: 1) a preliminary effect size
of semaglutide microdosing (0.5 mg subcutaneously weekly) in maintaining weight and cardiometabolic benefits
in PWH following induction therapy and 2) the tolerability and acceptability of semaglutide induction (2.4 mg
subcutaneously weekly) and microdosing in PWH. We will accomplish this novel work in two aims: Aim 1: To
determine the rate of weight regain in PWH receiving semaglutide microdosing following induction
therapy. Thirty adult PWH will be given semaglutide titrated to 2.4 mg subcutaneously weekly for 12 weeks
(induction), followed by 2:1 randomization to maintenance with semaglutide 0.5 mg sc weekly (n=20) or no
additional drug (n=10) for an additional 48 weeks. Using participants as their own controls, we will determine if
microdosing provides at least partial efficacy in preventing weight regain in PWH. These critical preliminary data
will inform sample size calculations for a larger RCT of incretin microdosing. Aim 2: To determine preliminary
effect sizes of semaglutide microdosing on additional endpoints. To ascertain the preliminary efficacy of
semaglutide microdosing in maintaining cardiometabolic benefit, we will measure fat and lean mass quantity and
distribution by dual energy x-ray absorptiometry, muscle function by physical function testing, circulating
cardiometabolic and inflammatory biomarker profiles, health self-perceptions during the induction and
maintenance phases and tolerability and acceptability of microdosing among PWH. These data will inform
secondary and exploratory endpoint effect size determination for a larger, future RCT. Development of
microdosing as a strategy to maintain weight and cardiometabolic health in PWH following induction therapy is
novel, important and will also inform intervention strategies in populations without HIV, providing significant value
added.

Public health relevance
PROJECT NARRATIVE Long-acting glucagon-like peptide-1 receptor agonists (GLP-1RA) induce weight loss and provide cardiometabolic benefit in people living with HIV, among whom obesity is a major driver of cardiometabolic risk. Weight regain following GLP-1RA cessation is well described and likely leads to at least partial loss of cardiometabolic benefit, but there are no current strategies to maintain weight loss after GLP-1RA cessation therapy in people with or without HIV. The proposed work will help fill this critical knowledge gap by testing a GLP-1RA microdosing strategy to maintain weight loss and cardiometabolic benefit following induction therapy.